Vaccine and Treatment Evaluation Unit - Clinical Operations Support for Zika Virus

This program is comprised of a consortium of individual contracts within academic centers and organizations that provide a ready resource for the design and conduct of clinical trials to evaluate promising products to combat infectious diseases. In general, products will be evaluated in normal healthy populations; however, access to special populations is also available. Focus on concept and protocol development, implementation and assay work for Zika virus studies.